Leadership, Planning and Evaluation

PROJECT SUMMARY – LEADERSHIP, PLANNING AND EVALUATION
Raphael Pollock, MD, PhD serves as Director for The Ohio State University Comprehensive Cancer Center
(OSUCCC). Dr. Pollock is assisted by a Senior Leadership team of nationally recognized leaders in cancer
research, clinical care, and prevention and education includes Peter Shields, MD (Deputy Director); William
Carson, MD (Associate Director for Clinical Research); Electra Paskett, PhD (Associate Director for Population
Sciences and Community Outreach); Patrick Green, PhD (Associate Director for Basic Science); Claire
Verschraegen, MD (Associate Director for Translational Science); Heather Hampel, MS, LGC (Associate Director
for Biospecimen Research); Sharyn Baker, PharmD, PhD (Associate Director for Shared Resources); Lawrence
Kirschner, MD, PhD (Associate Director for Education and Training); John Byrd, MD (Senior Advisor) and David
Gosky, MA, MBA (Executive Director for Administration). This highly experienced Senior Leadership team works
together to: ensure consistency in the shared vision and goals of the OSUCCC; foster synergistic and highly
collaborative interactions among the basic, population, translational and clinical research components of the
OSUCCC; effectively leverage all available resources at OSU, state and national levels; engage in clinical trials,
community outreach, education and mentoring; and oversee all activities of the OSUCCC. Continuous planning
and evaluation are key to the development and sustained excellence of the OSUCCC, and helps ensure its
strong scientific trajectory. Planning and evaluation by the OSUCCC External Scientific and Internal Advisory
Boards (ESAB and IAB, respectively), the Associate Directors Committee (ADC), and other councils provide the
Director and Senior Leadership ongoing guidance and support. The ESAB is the primary external mechanism
for objective review and oversight of the OSUCCC, including its progress in basic, translational, population and
community research, and its leadership and strategic direction. The ADC, Program Leaders Committee, Shared
Resource Team Leaders Committee, and IAB (composed of OSU deans and associate deans of research)
facilitate internal planning and evaluation. The Executive Council is responsible for the cohesive vision of cancer
research and clinical programs of the OSUCCC-James and provides another important internal mechanism for
planning and evaluation. Dr. Pollock and the Senior Leadership recently created the OSUCCC-James strategic
plan for the next five years, building upon existing strong foundations. The overarching goal of the new plan,
entitled Ascending to New Heights, is to drive new discoveries that transform cancer care across the continuum
of prevention, treatment and survivorship to improve the health of the OSUCCC catchment area communities.
Goals supporting research across the lifespan are informed by data about the cancer burden in the catchment
area and through bidirectional communication with community advisory boards. Four major research initiatives
(immuno-oncology, cancer engineering, translational genomics, and cancer prevention and survivorship) in the
plan will accelerate our vision of creating a cancer-free world, one person, one discovery at a time.